Spectral Resolution and Language in Children with Hearing LossILDREN WITH HEARING LOSS

Even with early identification and intervention, 30-40% of children with hearing loss (HL) do not acquire
language and academic skills that meet their developmental potential. Understanding this variability in
outcomes may help us predict who is at risk for persistent language delays even after being fit with hearing
aids. Current audiologic assessment of children lacks auditory measures that predict outcomes. Identifying
an auditory-based task that is predictive of a child’s language skills is of great value to stakeholders to
guide expectations and intervention of children with HL. Tasks measuring spectral resolution, such as
spectral ripple detection (SRD) tasks, may be predictive of language outcomes. Spectral resolution allows
listeners to differentiate variations in the speech spectrum that distinguish speech sounds. SRD tasks may
have clinical utility in measuring psychoacoustic skills in children with HL because some children show
reduced spectral resolution even after audibility is improved via hearing aids, such that some audible
sounds are unintelligible and loud sounds are distorted; however, there is limited research examining the
relationship between spectral ripple detection and individual differences in language outcomes in children
with normal hearing (CNH) or children with hearing aids (CHA). The current proposal will examine spectral
ripple detection as a predictor of language outcomes in school-age CNH and CHA. This proposal seeks to
test the central hypothesis that children with poorer SRD will have greater difficulty using the acoustic cues
that encode speech, resulting in reduced language abilities. In Aim 1, we will investigate SRD as a
predictor of language in CNH. We will assess CNH of a variety of ages on measures of SRD and spoken
language (i.e., morphosyntax, vocabulary). We hypothesize a child’s maturing SRD abilities will partially
account their improved language abilities as they age. In Aim 2, we will investigate SRD as a predictor of
language in CHA. In addition to the tasks in Aim 1, we will consider the impact of hearing loss (i.e.,
audibility via hearing aids) on these relationships. We hypothesize that audibility and SRD performance will
predict language outcomes. Results of the proposed study will elucidate the link between hearing and
language in typical development and in children with reduced audibility who use hearing aids. These
results will improve tools used to distinguish children who benefit from hearing aids from those who may
need changes to their devices (e.g., candidacy for cochlear implantation).

Public health relevance
Some children with hearing loss who use hearing aids are unable to close the gap in language outcomes with children with normal hearing even after early intervention. The proposed project aims to address this public health issue by examining spectral ripple detection as a predictor of spoken language in children with normal hearing and hearing aids. These data will result in more precise prediction of outcomes in this population, leading to improved assessment and individualized intervention for children with hearing loss.